The role of HOXD13 in controlling Ewing sarcoma cell plasticity and metastasis

Project Summary
Ewing sarcoma is an aggressive bone tumor that has a peak incidence in children and adolescents. Systemic
chemotherapy and local control measures have improved survival rates for patients with localized tumors
however, survival rates for patients with metastatic disease are dismal. Ewing sarcoma is defined by tumor-
initiating EWS-ETS fusion proteins, most commonly EWS-FLI1, that have remained undruggable, highlighting a
need for new strategies and therapeutic opportunities to improve patient survival.
EWS-ETS fusions induce malignant transformation by hijacking gene regulatory networks via enhancer
reprogramming. The putative cell of origin is a mesenchymal stem/progenitor cell derived from the neural crest
or mesoderm lineage. Aside from EWS-FLI1 fusion proteins, Ewing sarcoma tumors rarely present with other
recurrent mutations, however present with clinical heterogeneity. Tumor heterogeneity has become an important
concept in cancer research for studying metastasis and treatment response. Studies of other pediatric tumors
have demonstrated that the epigenetic and transcriptomic state of tumor cells and their inherent plasticity reflects
differences in biologic phenotypes, of which are required for metastatic progression.
Abnormal expression and regulation of developmental programs is evident and may in part explain the
undifferentiated features of Ewing tumors. Homeobox (HOX) genes are evolutionarily conserved transcription
factors that play essential roles in body patterning and embryogenesis. We have shown that posterior HOXD
gene expression is widely deregulated in Ewing sarcoma. In particular, our findings revealed HOXD13 to be
overexpressed in tumor samples relative to normal and other malignant tissues and critical for Ewing sarcoma
tumorigenicity.
My preliminary data reveal HOXD13 expression is maintained through EWS-FLI1-dependent enhancer
reprogramming and modulation of HOXD13 leads to opposing shifts in neural and mesenchymal lineage
programs, supporting the role of HOXD13 as a determinant of cell state. The working hypothesis is that HOXD13
regulates epigenomic and transcriptomic transitions in Ewing sarcoma cells and that these molecular transitions
drive phenotypic transitions between more proliferative and metastatic cell states. This hypothesis will be tested
in two aims. In Aim 1, I will determine if and how HOXD13 regulates Ewing sarcoma cell state. Aim 2 will define
the contribution of Ewing tumor cell state to the metastatic phenotype. Functional characterization of cell state
transitions, and the mechanisms underlying these transitions, will generate new insights into the biology of Ewing
sarcoma metastasis and provide novel opportunities for the development of therapies.

Public health relevance
Project Narrative Metastasis accounts for 90% of cancer-related deaths and is thought to be driven, in part, by tumor heterogeneity and cell state transitions. My project will investigate how HOXD13 regulates neural and mesenchymal cell states in Ewing sarcoma. A better understanding of the programs driving Ewing sarcoma heterogeneity will provide important insights into the biology of metastasis.